Child Abuse and Risk of Gynecologic Disease in a North American Cohort

ABSTRACT
Uterine leiomyomata (UL), endometriosis, and polycystic ovarian syndrome (PCOS) are debilitating gynecologic
conditions diagnosed in up to 30% of North American women. These conditions are associated with infertility,
pain, menorrhagia, and other sequelae that can profoundly affect quality of life. In the United States (US), annual
health care costs for treating these conditions exceed $3 billion. Childhood sexual abuse (CSA) is reported by
up to 25% of US women, but there has been limited study of its effects on gynecologic health. CSA has been
associated with altered regulation of the hypothalamic-pituitary-adrenal (HPA) axis and autonomic stress
response, demonstrating long-term effects on health that can persist into adulthood. Emerging research
suggests that exposure to CSA influences risk of gynecologic conditions. MPIs of the present application, Drs.
Boynton-Jarrett and Wise, have published studies from two US cohorts showing that early life abuse
victimization, particularly CSA, was associated with greater UL incidence and that resilience factors may mitigate
the adverse effects of CSA. Given the dearth of research in this area, and the potential role of moderators and
mediators, greater study of the effects of CSA on the occurrence of gynecological diseases is critical. With
ongoing NIH funding since 2013 (R01-HD086742), Pregnancy Study Online (PRESTO) has enrolled and
followed more than 17,200 female-identified participants—including more than 3,200 participants who identify
as Black, Indigenous, and People of Color (BIPOC)—residing in the US and Canada. Comprehensive data are
collected on socio-demographics, diet, behaviors, medical history, medication use, mental health, and stress,
including data on social determinants of health such as adverse childhood experiences, abuse, financial
hardship, and discrimination, as well as measures of resilience, social and emotional support, and coping. This
application will leverage the existing PRESTO infrastructure to assess the following hypotheses: CSA will be
associated with a greater risk of UL, endometriosis, and PCOS. Greater social and emotional support, resilience,
coping skills, and neighborhood cohesion will buffer these associations. Mental health conditions—depression,
anxiety, post-traumatic stress disorder (PTSD)—that develop after abuse initiation but before onset of
gynecologic conditions will mediate these associations. This study will be one of the largest investigations of
CSA and gynecologic disease. Added strengths include the comprehensive collection of data on abuse and other
adversities across the life course; proposed validation of gynecologic diseases using medical records; collection
of extensive data on potential moderators, mediators, and confounders; geographically dispersed and racially
diverse study population; and interdisciplinary research team. Preliminary data from PRESTO indicate wide
variability in exposure to CSA. Future research could build on this foundational work by linking CSA, gynecologic
disease, and fertility and perinatal outcomes in PRESTO. Findings could identify feasible targets for intervention,
and identify individuals who might benefit from greater provision of health care resources and social support.

Public health relevance
PROJECT NARRATIVE Gynecologic disorders are diagnosed in up to 30% of reproductive-aged North American women in their lifetime and they are associated with substantial morbidity, reduced quality of life, and high health care costs. The proposed study will evaluate the extent to which child abuse is associated with three highly prevalent and debilitating gynecologic diseases: uterine fibroids, endometriosis, and polycystic ovarian syndrome. The proposed research will provide important information to patients and clinicians about the importance of child abuse for development of gynecologic disease.